Development of Cavity-Enhanced Single-Molecule Electronic and Vibrational Spectroscopy for Mechanistic Studies of Biomolecules

Development of Cavity-Enhanced Single-Molecule Electronic and Vibrational Spectroscopy for
Mechanistic Studies of Biomolecules
Single-molecule (SM) measurements are a powerful mechanistic tool because they allow multi-step unsynchro-
nized dynamics to be directly observed. However, most SM observations rely on fluorescence, which lacks the
sensitivity to determine oxidation state, the chemical specificity to elucidate distortion of a particular chemical
bond, and requires a fluorescent label. Such information would revolutionize how biochemical mechanisms are
determined and could be provided by a method of performing electronic absorption and vibrational spectroscopy
on single operational biomolecules. However, surface-enhanced Raman spectroscopy (SERS) is not is suited for
probing complex biomolecules, as the method requires intimate contact between the part of the biomolecule to
be probed (which may be at the interior), and a metal surface. Similarly, methods exist for performing SM elec-
tronic absorption spectroscopy but they lack the required sensitivity or biocompatibility for biomolecules. Thus,
a new method is needed to allow SM investigations of in vitro molecular dynamics for mechanistic investigations.
We propose the use of optical microcavities as platforms for ultrasensitive SM electronic and vibrational
spectroscopy. In one geometry, microcavities are used as highly sensitive thermometers, capable of detecting the
heat dissipated by non-fluorescent molecules upon photoexcitation. In this way, non-fluorescent and potentially
even weakly absorbing spectral features, such as those diagnostic of the coordination environment of a metal-
loenzyme can be elucidated. In a second complimentary geometry we take advantage of the Purcell Effect, which
can significantly enhance scattering rates in optical microcavities with small mode volumes and high Quality
factors. While SERS requires essentially Van der Waals contact with a plasmonic surface, the microcavity en-
hancement can act at a distance of up to ~100 nm from a dielectric surface, making it suitable for probing bio-
molecules without significant perturbation. We have now demonstrated the core concepts behind these two strat-
egies. In Specific Aims 1-3, we will bring online and evaluate three new microcavity systems that promise to
significantly enhance our measurement capacity enough to lay a concrete path to biomedical applications: planar
silicon nitride ring resonators (SA 1), fiber Fabry-Perot microcavities (SA 2), and silicon nitride nanobeams
(SA3). In all cases we will perform spectroscopy on a series of particles and molecules of increasing challenge,
pushing toward the monitoring of a single working metalloenzyme. Supporting calculations suggest that these
new resonator geometries will increase our molecular signals by orders of magnitude. Our long-term objective
is to bring a new, highly informative, and even disruptive biophysical technique to bear on biological molecules
to understand how they operate, change in time, are regulated, and fail.

Public health relevance
Project Narrative Specialized techniques to allow observation of individual molecules are a particularly powerful way of learning about how biomolecules carry out their tasks, are regulated, change over time, and fail. We will increase the information content of single-molecule techniques by developing means of performing ultrasensitive electronic absorption and vibrational spectroscopy. This increased information will lead to new insights into the mechanisms of biochemical transformations.